Age-dependent SKN-1/NRF cytoprotection at the cost of metabolic homeostasis

Abstract
SKN-1/NRF2 is a conserved cytoprotective transcription factor that plays established dose dependent roles in
response to diverse cytotoxic stressors. As such, the degree of SKN-1/NRF2 activity can impact survival and
physiological responses to environmental toxins. Although it makes sense that increased SKN-1/NRF2 activity
could be protective, it remains possible that the NRF2 response itself contributes to disease pathology. As
such, a major question is whether SKN-1/NRF2 activation is universally helpful or if it can also drive pleiotropic
consequences over the lifespan. We have uncovered the existence of a conserved signature, defined by metabolic
dysregulation, in worms and mice with activated SKN-1/NRF2. These metabolic defects mask the potentially positive
cytoprotective effects of SKN-1/NRF2 activation later in life. The central hypothesis driving our proposal is that animals
with activated SKN-1/NRF2, have enhanced resistance to stress, but also increased incidence of metabolic disorders
that compromise health later in life; this ultimately diminishes life expectancy. To test our hypotheses, we propose two
interconnected specific aims. In Aim 1, we will biochemically define the age-related depletion of somatic lipids when
SKN-1/NRF2 is activated, which ultimately leads to reduced health later in life. We will also examine the lifespan and
healthspan of animals that where the somatic lipid depletion phenotype is suppressed, by genetic or nutritional
interventions, while SKN-1/NRF2 activation is maintained. This will functionally uncouple the positive and negative
effects of SKN-1/NRF2 activation on healthspan and lifespan. In Aim 2, we will define the mechanisms underlying
the metabolic and stress resistance phenotypes resulting from activated SKN-1/NRF2 by elucidating the molecular,
and spatial determinants of these responses, whose capacity is governed by age. Finally, in Aim 3, we will define a
new mechanistic link between lipid metabolism and immune activation that is governed by activated SKN-1/NRF. The
successful completion of the proposed research will inform strategies to capitalize on the health promoting benefits of
molecules like SKN-1 and NRF2 while avoiding pleiotropic outcomes over the lifespan.

Public health relevance
Project Narrative SKN-1/NRF2 plays established roles in xenobiotic responses. As such, the degree of SKN-1/NRF2 activation can impact organism survival during exposure to environmental and endogenous sources of stress. Our published and newly acquired unpublished preliminary data reveals the activation of SKN-1 in worms and NRF2 in mice and humans leads to metabolic dysfunction. Making use of our established C. elegans genetic systems this project will define a new platform for thinking about cytoprotection responses, which will inform strategies to capitalize on the health promoting benefits of molecules like SKN-1 and NRF2 while avoiding pleiotropic outcomes.